A Multi-pronged Computational Approach to Advance Kinase Drug Discovery

Project Summary/Abstract
In recent years, computing speed has exponentially increased; however, the potential of computational ap-
proaches to accelerate drug discovery has not been fully realized. Our long-term goal is to develop and ap-
ply computational tools to advance structure-based drug design. The objective of this proposal is to apply new
computational protocols based on the cutting-edge molecular simulation and quantum calculation tools to tackle
several critical topics in the rational design of reversible and targeted covalent inhibitors (TCI) of kinases. Kinases
phosphorylate a third of the proteome and deregulation of kinase functions is a major strategy to modulate cancer,
autoimmune and inﬂammatory conditions. In recent years, reversible and covalent kinase inhibitors are gaining
FDA approvals at a rapidly growing speed.
Supported by our new tool developments, pilot studies, unpublished preliminary data, as well as working hypothe-
ses, we will pursue three speciﬁc aims: 1) conduct kinome and proteome wide computational proﬁling studies to
identify covalent targetable sites; 2) elucidate the reaction mechanisms and structure-reversibility relationships
for chemical warhead design; and 3) elucidate the mechanisms controlling selectivity and kinetics of reversible
kinase inhibitors. The outcomes of the studies will guide the current efforts in TCI discovery for kinases and
the search for new druggable targets; provide detailed knowledge for attenuating reactivity and reversibility of
chemical warheads to minimize toxicity; and offer new strategies to improve selectivity and kinetic parameters
of reversible inhibitors. Successful completion of the project will allow us to build a computational platform to
advance structure-based drug design and expand the current therapeutic target space.

Public health relevance
Project Narrative Kinase inhibitors are gaining increased FDA approvals for treatment of cancer and other diseases. This proposal seeks to apply new computational protocols based on cutting-edge molecular simulation and quantum calculation tools to tackle several critical topics in the rational design of reversible and targeted covalent inhibitors of kinases. Outcome of the studies will accelerate the kinase drug discovery efforts and expand the druggable target space.